A Multilevel Physical Activity Intervention for South Asian Women and Girls

Project Summary
Asian Indian and Pakistani (South Asian) immigrants have a high prevalence of physical inactivity and
cardiometabolic risk factors. South Asian (SA) women and girls are particularly at high risk due to a confluence
of immigration, culture, and gender which shape the health risk of SA women and girls across the life course.
Our community-based participatory research found that SA women (85% of whom were 1st generation
immigrants) experienced: a) social isolation and low social support, which reduced physical activity (PA)
motivation and self-efficacy; b) desire to maintain traditional values and norms, which conflicted with local PA
environments (e.g., mixed-gender exercise classes); and c) linguistic and environmental barriers. When SA
girls (majority 2nd generation) entered adolescence, they described: a) acculturation-related family conflict
because exercise was perceived as an “American behavior”; b) gender constraints; c) lack of role models; and
d) their community's shared illness belief that “if you are thin, you don't need to exercise.” Importantly, the
community also identified individual, interpersonal, and familial processes that empowered SA women and girls
to become more active, including holistic benefits of PA, aspirations for children's health, and feeling
connected and happy when exercising with other women and family. Building on a pilot study demonstrating
feasibility and preliminary efficacy, the proposed study aims to testing the efficacy and implementation of the
South Asians Active Together (SAATH) intervention. The 16-week intervention targets individual,
interpersonal, and family levels through four main components: 1) group exercise classes for mother-daughter
dyads; 2) dyadic mother-daughter PA counseling using motivational interviewing; 3) peer discussion groups,
and 3) family walking groups. The intervention also targets the environment level by working with park districts,
a public health department, and community organizations to make changes to the local environment that take
into account sociocultural (e.g., gender, family focus) and environmental (e.g., same sex classes) expectations
of SA. Aim 1 of the study is to determine the efficacy of the SAATH intervention to increase moderate-vigorous
PA in SA mother-daughter dyads using a randomized wait-list control study design. Secondary outcomes are:
walking and sedentary time in dyads and cardiometabolic risk factors in mothers. Aim 2 will evaluate the
impact of the intervention on individual (self-efficacy, autonomy support, social support, motivation) and dyadic
(acculturation conflict, communication, connectedness) factors hypothesized to mediate the intervention effect
on PA. Aim 3 is to evaluate implementation and sustainability of SAATH, including the environment and
systems changes made by cross-sector partners to promote and sustain PA in SA women and girls. Given the
growth of the SA population and their increased risk for cardiometabolic disease, identifying interventions that
increase PA among Asian Indian and Pakistani immigrant women is of significant public health import.

Public health relevance
Project Narrative South Asian immigrant women and girls are at increased risk for insufficient physical activity and are not being reached by current approaches to physical activity promotion. This randomized control trial study will test the effectiveness and implementation of a multicomponent physical activity intervention directed at the environment, family, interpersonal and individual levels to promote physical activity among South Asian immigrant mothers and daughters.